COUNTERREGULATORY RESPONSE OF HUMANS WITH AND WITHOUT DIABETES TO EXCERCISE

A study of normal patients with diabetes of the effect of absolute blood sugar levels on the subjects' ability to secrete counterregulatory hormones in response to exercise.